Core A: Administrative and Enrollment Core

Administrative and Enrollment Core (Core A) Abstract
The Administrative and Enrollment Core (Core A) is mandated by the PAR and will oversee, facilitate and
coordinate all ACAD activities carried out by other Cores and Projects. Using a robust administrative structure,
the Core directs the ACAD’s activities to ensure maximal coordination and produce cutting-edge science to
support the ACAD project. Core A will identify relevant ADRD data sets (ADGC, ADSP and non-ADSP data),
and coordinate acquisition, processing, and harmonization of these data with the Data Management and
Analysis Core (Core D) and Projects. Data will include: 1) genetic data (GWAS SNP array data), 2) biomarker
and functional genomics (FG) data, and 3) phenotype data from ACAD participants and other non-ACAD
datasets. Core A will coordinate transfer of ACAD data and analysis results to National Institute on Aging
Genetics of Alzheimer’s Disease Storage site (NIAGADS) for sharing with the general scientific community.